Reducing Alcohol-Related Sexual Risk Behavior

Abstract
The purpose of this administrative supplement is to provide sufficient funding to carry out the proposed
work. Although we have worked diligently to develop the prevention program and procedures for data
collection and have begun data collection for Phase I of the study, our progress has been slowed by the
COVID-19 pandemic. Teaching and administrative demands on the PIs (e.g., moving courses online,
managing graduate student challenges related to the pandemic) have impacted our progress in meeting
project goals. In addition, there have been periods of time that the IRBs at both institutions have prevented in-
person data collection. Despite these challenges, we were ready to begin data collection in the summer of
2021, but recruitment was challenged by the lack of students on campus because most courses were offered
remotely. Thus, we are just beginning to run participants through Phase I of the project. Because these
disruptions were unpredictable and repeated, it was not possible to simply suspend the project and wait to
resume at a later point in time, which would have preserved our budget for completing the project. Thus, we
have utilized our budget to ensure readiness for data collection on an unpredictable schedule. Further,
although our progress with data collection has been slowed by COVID-19 related challenges, we have utilized
our relatively limited committed effort both to strengthen the empirical foundations of our prevention program
and to develop enhancements that we believe will increase the efficacy of our program. Our request for an
administrative supplement will provide additional support via increased PI effort, and additional graduate
research assistant support and supplies for recruitment during year 3 of the project. This will provide adequate
resources to continue data collection on the RCT through the fall of 2022. The no-cost extension year will be
used to analyze the results and disseminate the findings, and to submit a follow-up grant proposal to build
upon the findings of this R34 project.

Public health relevance
Project Narrative Heavy drinking, sexual aggression, and risky sexual behavior among college men are closely linked and important public-health issues with enduring physical and mental-health consequences. Because current prevention programs are only minimally effective, the current proposal develops and evaluates the first computerized prevention program that simultaneously targets all three problem behaviors using a combination of personalized feedback and cognitive-training strategies. Evidence for the efficacy of this approach would have substantial public health implications given high rates of these risk behaviors in college men and our ability to translate this approach into a fully web-based program for broad dissemination.